Vector mediated anti-vascular and anti-inflammatory therapy for AMD

Abstract
Bedrock Therapeutics, Inc., is developing a method of controlling the inflammatory, vascular, and immunologic response
in neovascular age-related macular degeneration (nAMD). nAMD is the leading cause of blindness in people over 50 years
of age. Intravitreal (IVT) injection of anti-vascular therapy has been successfully used in the past decade to reduce and
delay the onset of blindness in patients, however, regular monitoring and repeat monthly treatment are required. Even
with this therapy, substantial visual decline due to macular atrophy occurs in nearly half the patients. Further, risks of
repeated IVT injections can be severe, including endophthalmitis, and prolonged anti-vascular use may increase the risk
of systemic adverse events in patients with diabetes, such as thromboembolism. Finally, up to one-third of nAMD patients
treated with anti-vascular treatments, such as aflibercept, continue to have active retinal exudation. Therefore, a
significant unmet need exists for effective and practical treatment for nAMD. Bedrock has developed a potent HLA-G-
derived therapeutic strategy using AAV gene delivery that is both safe and effective for treating various ocular diseases
caused by inflammation and/or neovascularization. This strategy combines two of our licensed products, a novel
neutralizing antibody evasive capsid derived from human tissue, AAVLP2-10, and our single-chain ImmunoModulating
transgene (scIM). scIM proteins are secreted and overcome the rate limiting steps for anti-vascular and
immunomodulatory activities of Human Leukocyte Antigen G (HLA-G), which are natural proteins that induce ocular
immune privilege and also act to prevent maternal rejection of the developing fetus. Our innovative optimized gene
therapy for the treatment of vascularization and inflammation of nAMD will rely on the combination of our human
tropic AAV capsid and our novel engineered, HLA-G-based, scIM transgene (collectively termed BDRK-501). This
therapeutic shows great promise in solving the unmet need for a safe and effective single-dose drug for nAMD and other
back-of-the-eye diseases, such as diabetic macular edema. Bedrock Therapeutics proposes in this Phase I application to
produce BDRK-501, establish BDRK-501 potency assays (Aim 1), and determine the efficacy of BDRK-501 in a well-
described model of nAMD, the rat laser-induced choroidal neovascularization (CNV) model (Aim 2).

Public health relevance
Project Narrative Bedrock Therapeutics has developed a single dose, gene therapy technology that relies on the use of adeno- associated virus to deliver a novel engineered, HLA-G based, single chain immunomodulatory (scIM) protein to control the neovascularization and inflammation associated with neovascular age-related macular degeneration.